Metal-induced cell-level changes in prostate epithelium and cancer risk

1 Data in the Veterans Affairs (VA) Central Cancer Registry showed nearly 50,000 new cases of
2 cancers were diagnosed in the VA system in 2010, and prostate cancer (PCa) is the most frequently
3 diagnosed cancer among male veterans, with ~12,500 cases or 33% of all cancers reported.
4 Inhalation or ingestion of toxic air from incomplete combustion are known to increase exposure
5 to metal ion including lead (Pb) and arsenic (iAs), especially when a great variety of materials
6 were being burnt in burnpit. iAs and/or Pb exposure have been considered as potential risk factors
7 for this cancer, but the underlying mechanism is largely undefined. In a small clinical study, we
8 found that iAs and Pb levels were significantly higher in the urine of PCa patients. Using a new 2-
9 hit animal model we established, exposure to iAs or Pb was showed to increase (1) PCa risk in
10 vivo, and (2) the ability of prostate epithelial stem-like cells (PrESLCs) isolated from treated
11 animals to form colonies in soft agar, a hallmark of cellular transformation. In this animal model,
12 a 1-month metal treatment followed by chemical carcinogen treatment, resulted in significant
13 increases in PCa incidence and pre-cancerous lesions in iAs-treated animal and trends of increases
14 in Pb-treated animals. Importantly, single-cell RNAseq analyses revealed that Pb was associated
15 with the expansion of a subpopulation of PrESLCs with epithelial lineage markers into stroma-
16 like oncogenic cells, while iAs was associated with the emergence of a rare, unique subpopulation
17 of oncogenic PrESLCs similar to “cancer” stem cells. This application will test the hypothesis that
18 iAs and/or Pb dysregulate specific, and likely different, signaling pathways in subpopulations of
19 prostate epithelial stem-like cells (PrESLCs) to initiate or increase the risk of carcinogenesis in the
20 gland. This is an untested hypothesis in the field of prostate carcinogenesis and in military veterans’
21 health. Two Aims were proposed: 1) Determine the carcinogenic potential of metal-treated prostate
22 epithelial stem-like cells (PrESLCs) in vivo using a renal grafting model of PCa formation assay.
23 We will evaluate the effects of metals on to form PCa in vivo in immune-deficient host mice, either
24 with or without chemical induction of PCa; and 2) Characterize stem-like cells with metal-specific
25 transcriptomic signatures. We will use single-cell RNA sequencing and visualization informatics
26 to identify the unique gene signatures that characterize rare subpopulations of metal-induced
27 cancer stem cells within the PrESLCs population. We aim to apply these gene signatures to enrich
28 rare subpopulations by FACS and evaluate their carcinogenic potential. We will also leverage The
29 Cancer Genome Atlas PCa data and other online databases to enable accurate classification of
30 major, rare, and heterogeneous subtypes of PrESLCs to gain insights in metal carcinogenesis.
31 Findings from the proposed work may address questions related to occupational and post-
32 deployment exposure and expand our knowledge on stem cell biology. Potential Impact on
33 Veterans Health Care: Successful completion of these studies can potentially lead to the
34 development of new PCa prevention and therapeutic strategies. Plans to reduce unnecessary
35 exposure to those metal ions should be implemented as effective strategy for PCa prevention.
36 Drugs targeting to specific subpopulation of stem cells could be used as therapeutic options to
37 prevent early PCa development as well as progression. When applied to veterans, the results of
38 this study may allow saving human lives, improving the health of veterans, and decreasing the
39 number of disabilities in the veteran population.

Public health relevance
PROJECT NARRATIVE Prostate cancer (PCa) is a major health issue among military veterans in the United States. Environmental exposures during deployment and post-deployment likely have significant impacts on PCa risk in veterans. Inorganic arsenic (iAs) and lead (Pb) are classified as a carcinogen/potential carcinogen in humans. The post- deployment demographic data and occupations suggest a potential risk for veterans to be exposed to metals, such as iAs and Pb, in environmental as well as occupational settings. However, the underlying molecular mechanisms that link metal exposure and prostate cancer are understudied. This application will test the hypothesis that iAs or Pb transforms prostate epithelial stem-like cells to initiate or increase PCa risk in a mouse models. Our findings with a novel approach of single cell RNA-seq will reveal this rare epithelial stem cell population in the adult prostate as the possible origin of metal-associated prostate cancer, and provide novel specific biomarkers that will advance our current strategies in assessing the risk and treating the human disease.